Human Factors and Systems Integration in High Technology Surgery (HF-SIgHTS)

PROJECT SUMMARY
Surgery remains a high-risk endeavor, with upwards of 4000 “never” events per year, and multiple additional
opportunities for accidental injuries. Though new surgical technologies are intended to benefit patients, they
can introduce unexpected new complexities and error modes for which operating room (OR) teams and host
organizations may be unprepared. One of the most ubiquitous exemplars of high-technology surgery is robotic
assisted surgery (RAS), which has demonstrated benefit, but also introduces a range of new challenges that
place additional stresses on communication, technical and procedural knowledge within the team, and the
available space in the operating room. We will evaluate multiple interventions to address these specific
challenges, testing new approaches to teamwork training, task design, and workspace management both
individually and in combination, at 4 different hospital sites. The effects will be evaluated at individual (use of
intervention; workload), process (surgical durations and disruptions) and systems (complications and safety
culture) levels. Qualitative interviews and observations will be used to understand the implementation and
spread of the interventions. Finally, data from the 680 planned surgical observations – the largest direct
observation study ever conducted – will be used to model accident causation by exploring the mechanism by
which small innocuous process problems concatenate into more serious risks and eventual injuries. This will
fundamentally improve our understanding of how innovative surgical technologies can be safely deployed and
integrated within complex clinical work systems.

Public health relevance
PROJECT NARRATIVE Though new surgical technologies are intended to benefit patients, they can also introduce new stresses on teamwork, technical knowledge, and functional space in the operating room. We will evaluate multiple interventions to address these specific challenges in Robotic Assisted Surgery, studying both whether and how they work and can be spread. This will be the largest study of this kind ever conducted, allowing us to explore the causes of errors in more detail than ever before, and fundamentally improving our ability to make the best use of innovative surgical technologies.